UTS-1401 as a Medical Countermeasure to H-ARS Consequent to a Radiation Mass Casualty

Abstract:
Our long term objective is to develop a new class of radiation mitigating agents with attractive chemical,
physical and biological characteristics required to be an effective drug that can be distributed widely. We have
identified a small molecule, UTS-1401 [5-(methylthiomethyl) isoxazole-3-carboxylic acid] which demonstrates
mitigation of hematopoietic stem cell death when administered at either 24h or 48h following whole body
irradiation (WBI). Using the endogenous spleen colony assay, we demonstrated a mitigating effect in that the
colony number with and without UTS-1401 was 3.5 ± 0.4 for a 24h interval and 2.3 ± 0.5 for a 48h interval. We
have recently demonstrated a significant radioprotection for both mouse survival and hematopoietic stem cells
for this compound when administered up to 72h before irradiation (Valeriote et al, Radiation Research, 202:16-
25, 2024). In this application, we propose to further examine solely the mitigating effect on the hematopoietic
acute radiation syndrome (H-ARS) using survival as the endpoint in specific aim 1. Groups of Swiss mice will
receive a series of graded doses of WBI (in 0.5 Gy increments) around the LD50 for this syndrome (approximately
7.5 Gy in females and 8.5 Gy in males) with and without the administration of 150 mg/kg UTS-1401. The single
dose of UTS-1401 being used in all studies is the highest dose administrable due to its aqueous solubility (in
tartrate buffered saline). The radiation mitigation factors will be calculated as the ratio of the LD50 for radiation
plus UTS-1401 versus that for radiation alone. The degree of mitigation will be examined at 24, 48 and 72 h
following WBI to determine the radiation mitigation fraction as a function of time after radiation exposure. Three
routes of drug delivery, intravenous (iv), oral, and subcutaneous (sc), will be examined and compared. Radiation
will be delivered by 16 MeV electrons from a Linac. In specific aim 2, we will examine the pharmacokinetics
(PK) for 150 mg/kg UTS-1401 comparing the iv, oral, and sc routes to obtain a determination of both the drug
kinetics and bioavailability. The AUC values will be correlated with the extent of mitigation. For both specific
aims, both male and female mice will be separately studied. The results from these studies are expected to
demonstrate an effective first-in-class compound, UTS-1401, which has a small molecular weight, is chemically
stable, nontoxic, aqueous soluble and inexpensive with H-ARS radiation mitigating properties which extend for
a number of days following WBI. The mechanism studies (not proposed here) are expected to demonstrate UTS-
1401 as a new class of agents for mitigating the cytokine storm consequent to the irradiation.

Public health relevance
Narrative The objective of this research is to demonstrate that a new compound, UTS-1401, has superior chemical and biological properties to current medical countermeasures to limit the lethal damage suffered, specifically to the hematopoietic system, by exposed individuals following a nuclear disaster including war, terrorism, reactor malfunction or inadvertent exposure to ionizing radiation. The ability of UTS-1401 to increase the survival of both male and female mice exposed to high dose, whole body irradiation at intervals longer than current radiation mitigating agents (radiation countermeasures) following exposure will be studied and correlated with UTS-1401 levels in the blood of the irradiated animals. Further, we will demonstrate that UTS-1401 can be effective when administered by either the intravenous, oral or subcutaneous route making it a first-in-class mitigating agent to provide a cost-effective, stable and versatile addition to the USA defense against radiation incidents.